Structured Peer-delivered ART and Reentry Community Strategy (SPARCS) to overcome barriers to HIV care continuity during community reentry from incarceration in South Africa

PROJECT SUMMARY
HIV remains the leading cause of death among adults in South Africa despite the availability of antiretroviral
therapy (ART) due to failure to initiate ART and failure to remain on ART. Gaps in HIV care are especially
prominent among key populations at high risk for both HIV and reduced use of HIV services. One population
with an HIV prevalence double the age and sex-matched general population (23%) and with low engagement
in HIV care is individuals recently released from incarceration. During incarceration >90% initiate ART;
following reentry into the community only 34% remain in care. The transition from the controlled carceral
environment and its restricted autonomy to life in the community requires reestablishing planning skills, self-
efficacy, and social support and overcoming bureaucratic barriers to accessing community clinics. We have
demonstrated that an intervention that circumvents clinic barriers by directly providing ART and builds
behavioral skills through peer-facilitator led group sessions improves care continuity following release from
incarceration. In a pilot study of this intervention supported by NIMH, termed SPARCS, among 176
participants, 36% of those in the care as usual compared to 61% of those in the intervention arm were in-care
6 months after corrections release. These results raise important questions regarding possibility of
programmatic scale-up. Scale-up requires achieving a balance between effectiveness, feasibility, and cost.
Notably, the tension between effectiveness and feasibility may require reducing overall effectiveness – such as
by eliminating a component of SPARCS – to increase feasibility. To explore each of these questions, we are
proposing a hybrid type I effectiveness-implementation study structed with the RE-AIM framework (Reach,
Effectiveness, Adoption, Implementation, Maintenance). First, we are proposing a 2x2 factorial design to
maximize power of a randomized controlled trial of the Full-SPARCS intervention and the two distinct
components termed “ART-SPARCS” and “Group-SPARCS” and usual care, to test for a difference in viral load
suppression 6 months from correctional facility release. Second, we propose characterize implementation in
terms of reach, adoption or adoption potential, acceptability, and fidelity. Finally, will use findings from the RCT
to inform costing and cost-effectiveness to inform policy makers regarding cost of SPARCS and components
and cost-effectiveness of each component and the full SPARCS to inform implementation cost and potential
long-term sustainability or maintenance. This project has the potential to generate considerable new
knowledge on interventions that can improve care continuity for this population and key findings for potential
scale-up relevant to policy makers. This proposed study has the potential to generate actionable knowledge to
improve outcomes for community reentrants and contribute to overall goals of HIV epidemic control.

Public health relevance
Project Narrative Although most of the 23% of incarcerated people in South Africa who are also living with HIV initiate antiretroviral therapy (ART) during incarceration, only one third remain on ART following release. We pilot tested an intervention that succeeded in retaining 61% of individuals in care compared to 36% with usual services: Structured Peer-delivered ART and Reentry Strategy (SPARCS). We are seeking to conduct a randomized control trial that addresses the tension between effectiveness and scalability by: (1) testing each of the SPARCS components independently in a randomized controlled trial with a 2x2 factorial design trial to maximize statistical power, (2) identifying key elements of implementation including reach, adoption, adaptations, and fidelity, and (3) provide cost and cost-effectiveness results to guide scale-up decisions.